The University of California San Diego (UCSD) 2019 Urobiome Conference

Project Summary/Abstract The Urobiome Conference will be held at the University of California San Diego (UCSD) in February 2019 in conjunction with an International meeting of UCSD's Center for Microbiome Innovation, led by a world-renown microbiome researcher, Rob Knight PhD. The human urobiome is a rapidly growing area of scientific research that may inform prevention, diagnosis and treatment of multiple benign urologic conditions of interest to the NIDDK and other NIH institutes. The recent discovery of the urobiome has opened opportunities for additional scientific investigations that can refine the current body of evidence for these conditions. However, there are few investigators trained to participate in the team-based approach necessary for quality urobiome research. The Urobiome Conference will bring together leaders in the field to share their expertise and connect with interested investigators who are new to urobiome research. Drs. Brubaker and Knight have formed a collaboration designed to broaden the breadth and depth of urobiome work, regionally, nationally and internationally. Conference goals include connecting individuals interested in urobiome research to the larger, established international group of microbiome experts. The Urobiome Conference will also provide training and mentorship to a cadre of competitively-selected junior investigators who will receive modest travel awards from this R13 Conference Grant. Small group sessions and workshops will help individuals make the most of publically available resources that can advance urobiome research.

Public health relevance
Project Narrative The University of California San Diego (UCSD) 2019 Urobiome Conference (February 2019) will address the needs of the scientific community who is investigating the recently discovered human urobiome, a rapidly growing area of scientific research that may inform prevention, diagnosis and treatment of multiple benign urologic conditions of interest to the NIDDK and other NIH institutes. The Urobiome Conference will bring together leaders in the field to share their expertise and help interested individuals participate in the team- based approach necessary for quality urobiome research, connecting existing investigators to individuals who are new to urobiome research. Competitively-selected junior investigators will receive modest travel awards from this R13 Conference Grant to facilitate their participation in the Urobiome Conference which will include mentoring, small group sessions and workshops to help early stage investigators make the most of publically available resources relevant to urobiome research.